Computationally Enabled Integrative Neuroscience

Summary / Abstract
!
The Brain and Cognitive Sciences (BCS) Graduate Program at the Massachusetts Institute of
Technology (MIT) proposes the “Computationally-Enabled Integrative Neuroscience” (CEIN)
predoctoral training program. Tremendous advances in the field of neuroscience are beginning to
enable an integrated understanding of the brain. A convergence of new tools and methods, from
optogenetics to CLARITY to CRISPR to deep neural network modeling and machine learning, is
providing the means to address problems that once seemed intractable. MIT's BCS department is
ideally organized to promote interdisciplinary, integrative training and research in neuroscience and
behavior, combining the empirical power of modern molecular, cellular, systems and behavioral
methods, with the theoretical and model-building strength of computational neuroscience and
artificial intelligence. With world-renowned faculty and access to state-of-the-art equipment, CEIN
trainees will be poised to lead the next generation of basic and translational neuroscience.
The proposed CEIN training program maintains BCS's longstanding strength of integrative training
across levels of empirical analysis. In addition, the proposed program reflects significant evolution in
our field: the increased importance of computation in both data analysis and complex model
building, and the increased importance of professional skills for leadership. The CEIN training
objectives are focused on three training pillars (1) advancing empirical methods and concepts at
multiple levels of neuroscience (2) computational approaches to theory development and brain data
analysis, and (3) professional skills such as grant-writing, oral presentations, and clinical connection.
Supported by MIT's world-class facilities, resources, and faculty, predoctoral students will achieve
these goals through comprehensive coursework, new modules for professional skills development,
mentorship by experts in the field, and advanced research experience.
The research of CEIN trainees will lead to profound new discoveries about brain function in health
and its modes of failure in disease. Insights from CEIN laboratories will impact diagnosis and
treatment of Alzheimer's Disease, Autism Spectrum Disorders, dyslexia, hearing loss, and many
other disorders with increasing impact on heath in the United States.
The CEIN program is focused on training students in their first two years of graduate school. Funds
are requested for five years to support 11 predoctoral trainees per year. The CEIN training program
would be the only foundational neuroscience predoctoral training program at MIT.

Public health relevance
Project Narrative ! The “Computationally-Enabled Integrated Neuroscience” (CEIN) training program will prepare the next generation of leaders in neuroscience at MIT. The program will train exceptional predoctoral students to integrate neuroscientific experimental methods and concepts across multiple levels of analysis, build precise quantitative models, adhere to the highest standards of methodological rigor, and translate fundamental discoveries about brain function to new treatments and therapies for neurological disorders. !